Interferon E as a Tumor Suppressor and Potential Therapeutic in Pancreatic Cancer

PROJECT SUMMARY/ ABSTRACT
Loss of chromosome 9p21.3 is the most common homozygous deletion across cancers, including pancreatic
ductal adenocarcinoma (PDAC), and it is strongly linked to poor prognosis and increased resistance to immune
checkpoint blockade (ICB). 9p21.3 deletions invariably affect the tumor suppressor genes CDKN2A/B, yet often
include a linked cluster of type I interferon (IFN) genes, which encode cytokines with antiviral, antiproliferative,
and immune modulatory effects. While often overlooked, our laboratory recently found that co-deletion of the
entire type I IFN cluster contributes to an immunosuppressive microenvironment, leading to reduced immune
surveillance, increased metastasis, and resistance to ICB in mouse models of PDAC.
Preliminary data suggest that co-deletion of Ifne, the type I IFN gene closest to Cdkn2a/b, is sufficient to disrupt
tumor immune surveillance and promote metastasis. The overall objective of this proposal is to understand the
role, regulation, and therapeutic potential of Ifne in PDAC immune surveillance.
Aim 1: Determine the specific contributions of IFNE to tumor immune surveillance. I will decisively assess
if Ifne is a tumor suppressor in the context of Cdkn2a loss by evaluating the effects of Ifne deletion in orthotopic
PDAC mouse models by measuring tumor growth, metastasis, and immune infiltrates. I will also test recombinant
IFNE (rIFNE) as a potential therapy.
Aim 2: Characterize the regulation of Ifne during PDAC tumor progression. I will profile Ifne expression in
PDAC and the tumor microenvironment and will test the hypothesis that Ifne is induced early during tumor
development by mutant Kras signaling.
Training plan: I will work with an interdisciplinary team of mentors and collaborators to gain expertise in cancer
biology, molecular and cell biology, and immunology. The skills that I will develop over the course of this project
will prepare me for a career as an independent researcher.

Public health relevance
PROJECT NARRATIVE Homozygous deletions of chromosome 9p21.3 occur in ~30% of human PDAC cases and are strongly linked to poor overall survival and altered immune infiltration. Around half of PDAC 9p21.3 deletions encompass type I interferon genes, and their loss contributes to an immunosuppressive tumor microenvironment, with Ifne suggested to play a dominant role. This proposal will determine the tumor suppressive role and regulation of Ifne, which can be leveraged to develop improved therapies for patients harboring 9p21.3 deletions.